Training for Health Professionals

ABSTRACT
As documented in the US Surgeon General's Call to Action to Promote Sexual Health and Responsible Sexual
Behavior, training of health providers in sexual health care is critical to addressing a broad array of the nation's
sexual and reproductive health concerns. Yet rigorous trials evaluating the effects of sexual health curricula on
provider behavior are rare. In sub-Saharan Africa, an environment which has the highest rates of HIV, STI,
teen pregnancy, unwanted pregnancy, unsafe abortion, child marriage of girls and sexual assault of boys in the
world, and where female genital cutting, wife-beating, marital rape, criminalization of homosexuality,
stigmatization of Lesbian, Gay, Bisexual and Transgender (LGBT) persons, myths about masturbation leading
to dysfunction, and rates of sexual dysfunction in both men and women are common, we could find no
formalized training of health providers in sexual health care. Sexual health education, even of health providers,
is a sensitive issue in Africa. Consequently, a rigorous study of its effects is needed, if such education is to be
widely adopted. Recently, at Muhimbili University of Health and Allied Sciences (MUHAS) in Dar es Salaam,
we adapted a PAHO/WHO sexual health curriculum training for healthcare providers for implementation in
Tanzania. Participants were 87 nursing, midwifery, and allied health science students. Pre-post evaluations
show the curriculum to be highly acceptable, needed, and desired by students, feasible in implementation, and
effective in improving student knowledge, attitudes, and skills in providing sexual health care to patients. The
logical next step in this line of research is to conduct the first rigorous trial of a comprehensive sexual health
training curriculum for health professionals in Tanzania. There are three specific aims. Aim 1 is to conduct a
social ecological needs assessment of sexual health care delivery in Tanzania. To determine whether
midwifery, nursing, medical, and allied health science students would benefit from one curriculum or separate
curricula tailored by discipline, we will conduct focus groups (3 from each discipline). We will also conduct
individual interviews with key informants to address structural and cultural issues. In Aim 2, we will further
adapt our curriculum, ensure it is culturally tailored to the Tanzanian/sub-Saharan context, and pilot test it. Aim
3 is to evaluate the effectiveness of an African-based, culturally-appropriate, sexual health curriculum. We will
conduct a randomized, controlled, single blinded trial of the curriculum against a waitlist control assessing
effects on sexual health knowledge, attitudes, and counseling skills (n=206 students per arm; 412 in total).
Hypotheses will test if the curriculum is effective, and whether it is more effective for one discipline than
another. If effective, MUHAS has committed to implement the curriculum for all their health students. Given
MUHAS is preeminent in health student education across Africa, the curriculum assessed in this study has
high potential to be widely adopted as a new standard of training for health professionals across Africa.

Public health relevance
NARRATIVE Tanzania has among the worst sexual and reproductive health statistics of any country, yet health professionals receive almost no training in how to address sexual health concerns. To address multiple, intersecting, sex-related, epidemics, and to train the professionals who do everything from staffing clinics to writing national policies, we need effective, evidence-based, culturally-tailored, sexual health curriculum/a. This study will conduct the formative research needed to develop the strongest curriculum for Tanzania, revise and pilot test it, then we will conduct a randomized controlled trial of the intervention against a waitlist control, on health worker ability to effectively address sexual health concerns.